Neuronal Activity-dependent Pomoter Usage

ABSTRACT
Experience-dependent remodeling of neural circuits enables animals to adapt their behavior to ever-
changing environments. Neuronal activity-dependent molecular alterations, elicited by sensory inputs, at all
levels from transcription to post-translational modifications are the basis of neural rewiring. Not surprisingly,
impaired molecular responses to neuronal activity are a common hallmark of a broad range of cognitive
disorders, such as depression, schizophrenia, and autism. Thus, comprehending activity-dependent molecular
changes is crucial to understanding the mechanisms of these mental disorders. Over the past several years,
extensive studies have made excellent strides in profiling activity-dependent changes in the transcriptome,
alternative splicing, and proteome. These studies have provided significant new insights into how the brain
integrates sensory inputs and reorganizes specific neural networks.
However, a portion of the RNA molecule has escaped genome-wide scrutiny―the 5'-ends. Widely-used
RNA-seq methods underrepresent the 5'-ends of RNAs. Existing methods to profile transcription start sites
(TSS), however, predominantly represent the 5' ends; therefore, most of the transcriptome is absent in such
libraries, making it challenging to connect TSS usage to dynamic mRNA expression.
We recently developed a full-length nascent-transcriptome profiling method, Bru-seq-DLAF, which
combines sensitive detection of TSS and nascent RNA sequencing. With Bru-seq-DLAF, we have unveiled
tens of genes that dynamically change TSS upon reducing or increasing network activity. Most of these TSS
led to alterations in polypeptides at their amino termini. Furthermore, the protein isoforms were conserved
between mice and humans, indicating that activity-dependent TSS usage may represent a conserved new
layer of gene regulation underlying synaptic plasticity. The proposed research goals are to 1) thoroughly
characterize this novel phenomenon in mouse models and 2) determine the roles of activity-dependent TSS in
synaptic plasticity. We hypothesize that neuronal activity-dependent TSS controls synaptic plasticity by
changing the subcellular localization of proteins. Our team is uniquely poised to test this hypothesis with its
unified expertise in genomics and synaptic plasticity.
A positive outcome of the proposed study is to illuminate activity-dependent TSS selection as an
intricate molecular mechanism for synaptic plasticity. To our knowledge, our data represent the first genome-
wide characterization of TSS alterations upon extracellular stimuli in animal cells. Furthermore, many genes
that undergo activity-dependent TSS selection have been implicated in mental disorders such as schizophrenia
and autism spectrum disorders. Thus, the proposed study will improve the genetics of mental disorders and
guide future functional studies on disease-associated genes.

Public health relevance
Project Narrative The transcriptional response of nerve cells to sensory experience plays an essential role in cognitive function. The project team recently discovered sensory inputs can change the starting sites of transcription and seeks to determine the roles and molecular mechanisms of this phenomenon. Completion of the study will substantially improve our understanding of how the brain integrates sensory experiences into neural circuitries and how disruption of this process potentially leads to human cognitive disorders such as autism.